Targeting Metabolic Vulnerabilities to Restore Balanced Hematopoiesis during Aging

Project Summary/Abstract
The blood system deteriorates with age with the function of hematopoietic stem and progenitor cells
(HSPCs), specifically, declining. Frequently with age, driver mutations cause a smaller number of individual
HSPCs, or clones, to contribute disproportionally to differentiated blood progeny leading to hematopoietic
clonal dominance and increased rates of hematological malignancy and cardiovascular disease. This
accumulation of somatic mutations is common among many aged tissues. Alteration in the metabolic state of
aged HSPCs leading to impaired function is well documented however, metabolic heterogeneity among aged
HSPCs has only recently been appreciated. Whether the metabolic heterogeneity of aged HSPCs is clone
specific is unknown. The overarching hypothesis of this proposal is that hematopoietic clonal
dominance in aging is caused by a divergent metabolic state and correction of this divergent metabolic
state would restore hematopoietic function and decrease disease acquisition in older individuals.
I have demonstrated that HSPC clonal imbalance occurs in zebrafish in the absence of known driver
mutations, similar to humans, using a genetic barcoding strategy. Aim 1 of this proposal pairs single-cell
metabolomics and genetic cellular barcoding to identify metabolic alterations in dominant HSPCs in the
absence of known driver mutations during the K99 phase of this award. The second half of Aim 1, to be
accomplished during the R00 phase is to interrogate the metabolic pathways that differentiate dominant from
non-dominant HSPCs to identify therapeutic targets to prevent hematopoietic clonal imbalance with aging.
Using a method of combining mosaic editing of genes frequently edited in HSPCs of older humans and
colorimetric barcoding I have demonstrated that the choline pathway is perturbed in dominant HSPCs.
Pharmacological inhibition of choline lipid species production was sufficient to reduce mutant HSPC clonal
expansion. During the K99 phase of this award, I will determine the mechanism of this inhibitor to reduce clonal
expansion by performing intracellular methylome profiling. In the R00 phase I will test the relevance of this
pharmacological intervention in human HSPCs in a xenotransplantation setting. By understanding the
metabolic state of dominant HSPC clones during onset and progression in non-mutant and mutant contexts,
interventions can be designed and applied to prevent age-related declines of the hematopoietic system.
I have developed training goals that will center on 1) expanding my single-cell analysis skillset, 2) developing
my intracellular methylation experiment capabilities, 3) mastering human HSPC culture, 4) enhancing my
scientific communication, 5) growing my biology of aging footprint, and 6) growing my mentorship and
leadership skills. The research and training plan designed for this K99/R00 award will support my long-term
career goal to become an independent investigator at a research-intensive institution studying how metabolism
underlies the hematopoietic dysfunction seen in individuals as they age.

Public health relevance
Project Narrative The proposed project will elucidate the metabolic underpinnings of how certain hematopoietic stem and progenitor cells dominant the blood system in older individuals leading to increased risk of age-related disease. The viability of therapeutics to reduce clonal dominance by targeting the metabolic pathways altered in dominant hematopoietic stem and progenitor cells and the mechanisms by which they act will be determined.